Administrative Core

Administrative Project Summary
The long-term goal of the Johns Hopkins Center for Innovative Diagnostics for Infectious Diseases (JH-C[ID2)
is to accelerate infectious disease diagnostic point-of-care (POC) technology innovation and access to impact
global public health. The Administrative Core will communicate both internally at Hopkins and externally
through the POC Technologies Research Network (POCTRN), our website, and Dissemination Core outreach
to attract the best technology innovation developers to apply to our solicitations. For subawardees, the
Administrative Core will manage annual solicitations, issue subwards, monitor performance and finances
against milestones and budget, facilitate meetings, and integrate the work of the Cores through
communication, meetings, monitoring, and evaluation. The Administrative Core will assure that developers are
aware of and leverage: 1) on-line tools like self-assessment systems engineering, Tech Watch Database, on-
line courses, and website information; 2) biospecimens for early prototype testing and pre-clinical pilots
through the Clinical Core; 3) verification of prototype performance can occur through benchtop evaluations at
Johns Hopkins; and 4) multi-disciplinary subject matter expertise for key technical challenges. Through service
excellence, the Administrative Core will support the JH-C[ID]2 to reach its overall goals and specific aims, as
well as the goals of the POCTRN and its Technology Research Development Centers together with the
Coordination and Technology Support Center. As additional Rapid Acceleration of Diagnostics (RADx) funnels
to accelerate development of novel technology to address unmet need in new focal areas are opened, the JH-
C[ID]2 will continue to support the POCTRN to select meritorious projects and to provide clinical expertise and
diagnostic development subject matter experts as needed.